WNK1-dependent macropinocytosis mediates emergency myelopoiesis

PROJECT SUMMARY/ABSTRACT
Hematopoiesis ensures the continuous formation and turnover of blood cells during homeostasis, which shifts
drastically towards production of inflammatory innate immune cells upon infection. At steady state, myeloid
progenitors express a default signaling pathway essential for monocyte/macrophage production and require
extrinsic signaling and transcription factors to direct lineage commitment towards other myeloid cell fates. During
infection, coordination of cytokines and growth factors shifts myelopoiesis dramatically towards neutrophilia, a
process known as emergency granulopoiesis. For instance, neutrophil production during systemic infection is
boosted by over 10-fold, increasing cell numbers to over 1012 in a single day. Therefore, the rapid response to
lineage-specific cytokines and growth factors to drastically increase granulocyte output is essential for pathogen
clearance and host survival. Inappropriate lineage fidelity is exemplified by aberrant responses to infection
observed in systemic inflammation and septic shock, however, the cellular machinery necessary to shift lineage
commitment to emergency neutropoiesis remain poorly understood. Recently, we made the surprising discovery
that the chloride-sensing kinase with-no-lysine 1 (WNK1) is indispensable for myeloid progenitor fate, with
myeloid-specific deletion of Wnk1 incurring dramatic loss of tissue-resident macrophages, disrupted organ
development, systemic neutrophilia, and mortality by 4 weeks old. Mechanistically, the cognate CSF1R cytokine,
macrophage-colony stimulating factor (M-CSF), triggers macropinocytosis in myeloid progenitors, which in turn
induces phosphorylation and activation of WNK1. Absence of WNK1 or macropinocytosis inhibition drove
myeloid progenitor differentiation into granulocytes in vitro and in vivo. The goal of this proposal is to
mechanistically dissect the WNK1-dependent pathway initiated by M-CSF-induced macropinocytosis and to
investigate how this pathway is systematically shifted during emergency granulopoiesis.
During the mentored phase of this application, I will master new techniques such as subcellular fractionation and
macropinosome isolation. I will study how to analyze, integrate, and communicate complex functional genomics
and metabolomics data. Together with colleagues, we will develop new tools to assess the importance of
macropinocytosis during hematopoiesis in vivo, allowing us to understand how the contents of macropinosomes
inform myeloid lineage commitment. With the guidance of my mentoring committee, I will strengthen my scientific
and professional skillsets in preparation for the independent phase. During the independent phase, I will explore
targeting the WNK1 pathway during sepsis using small molecules. Further, I will combine my expertise in in vivo
sepsis models, emergency granulopoiesis, and neutrophil biology together with tools developed during the
mentored phase to understand how macropinocytosis influences the innate immune response. The proposed
project will allow me to successfully establish an independent academic research program.

Public health relevance
PROJECT NARRATIVE Emergency hematopoiesis induces the rapid expansion of inflammatory neutrophils during infection, a process which must remain tightly regulated as the overproduction of hyperactivated granulocytes underlies the disease progression of systemic inflammation into septic shock. Therefore, myeloid progenitor fate during emergency granulopoiesis must be carefully controlled at a molecular, cellular, and systemic level. This proposal aims to examine the machinery that regulates the dramatic shift in myelopoiesis towards emergency neutropoiesis, with the goal of targeting this pathway to reduce the adverse effects of an over-activated immune system during septic shock.